The molecular and cellular basis of cortical interneuron divergence

Project Summary
In this grant we propose three aims focused on exploring the predictions of these gene regulatory
networks (GRN) by examining how critical transcription factors influence parvalbumin (PV) and
somatostatin (SST) cortical interneurons (cINs) at early and late points in development (1a), as
well as explore the role of candidate disease genes that affect these populations (1b). In the next
two aims we then focus upon SST cINs as they settle within particular cortex laminae to explore
how extrinsic signals contribute to their diversity (2a,b) how mutations in the laminar specific
genes Fezf2 and Tbr1 affect SST cIN lamination, as well as using these methods in the context
of our gene regulatory networks (GRN) strategy to identify molecules that affects these
events(3a,b). This will allow us to test our hypothesis that cINs emerges from a combination of a
genetic program initiated upon them becoming postmitotic combined with non-autonomous
signals from pyramidal neurons at their settling position within cortical laminae.
A chief goal of my laboratory is to determine how changes in gene regulation create
cortical interneuron diversity and how perturbations in these programs result in brain disease.
By joining efforts with the Bonneau laboratory, whose expertise is in computational biology, we
propose to both create and test GRNs for parvalbumin and somatostatin cortical interneurons
across development. Combining this with the Fishell laboratory’s expertise in development,
genetics and circuit formation, we will explore in aims 2 and 3 the mechanisms by which non-
autonomous cues from pyramidal neurons shape developmental programs in SST cINs, as well
as their synaptic connectivity.
Together, this grant represents a broad scale effort to both develop and test the
robustness of GRNs by applying them to understanding gene regulation in developing cortical
interneurons, as well as to determine the extrinsic environmental signals from pyramidal cells
that shape both the development and connectivity of developing interneurons. From our
preliminary data it is evident that canonical cortical circuits are much more precise and specific
to particular subtypes. By defining their relationships, as well as the molecular mechanisms that
dictate their synaptic specificity, this work will greatly increase both our understanding of cINs,
as well as the microcircuits they contribute to. This in turn will greatly extend our understanding
of how discrete cIN and pyramidal neurons interact in the obligate lock and key mechanisms
that allow their assembly.

Public health relevance
Project Narrative At present there exists a schism between the rate of disease gene discovery and our present understanding of how mutations in such genes result in mental illness. Understanding of how mutations in these genes affect brain function at a cellular level has lagged behind. My proposal by coupling our expertise in studying the development of cortical interneurons, with the computational skills of the Bonneau laboratory, promises to bridge this gap.